Mechanisms of childhood obesity underlying the susceptibility to multisystem inflammatory syndrome in children (MIS-C)

PROJECT SUMMARY/ABSTRACT
Unpredictability is the hallmark of Multisystem Inflammatory Syndrome in Children (MIS-C). MIS-C is a
severe pediatric complication of SARS-CoV-2 infection. MIS-C is distinct from COVID-19. It is not associated
with pre-existing cardiopulmonary, autoimmune, or hematologic disorders. It can occur either during acute phase
with detectable SARS-CoV-2 virus, or in the post-infectious period of several weeks after acute infection. Milder
symptoms of MIS-C include fevers, rashes, and gastrointestinal symptoms, but can progress to cytopenias,
coagulopathy, myocardial dysfunction, coronary aneurysms, and/or shock. We and others have found that MIS-
C is associated with pediatric overweight and obesity, thereby identifying over 380 million children at risk for this
disease. The mechanisms by which overweight and obesity influence the development of MIS-C are unknown.
Until a vaccine against SARS-CoV-2 is globally available to all children, they will remain vulnerable to MIS-C.
Our preliminary studies indicate that MIS-C is a highly inflammatory disease that incites more severe
immune cell activation than COVID-19, particularly in overweight and obese children. Overweight and obese
children with MIS-C had more T cell lymphopenia and T cell activation than their normal weight counterparts,
suggesting an increased risk for more severe disease. Deleterious genetic variants increasing IFN and
inflammatory signaling were exclusively found in patients with MIS-C, rather than severe COVID-19. This is a
mechanistic counterpoint to defective IFN signaling associated with severe COVID-19 in adults. Our central
hypothesis is that pediatric overweight and obesity prime interferon signaling, thereby increasing T cell
activation and ultimately, the risk of MIS-C
Aim 1 will elucidate how pediatric overweight and obesity drive immune cell dysfunction during MIS-C.
The proposed studies will test the hypotheses that pediatric overweight and obesity are associated with more
severe MIS-C, characterized by excessive interferon signaling and T cell activation.
Aim 2 will identify mechanistic risk factors for MIS-C. The proposed studies will test the hypothesis that,
even in the absence of infection, circulating immune cells from overweight and obese children exhibit an
increased interferon signature that promotes T cell activation. We will develop a strategy for stratifying MIS-C by
integrating genetic screening with measures of body mass index.
Building on collaborations spanning over a decade and unique cohorts of children with MIS-C and/or obesity,
our investigator team brings expertise in MIS-C, host immunity, pediatric obesity and endocrinology, and
multiomics. This project will generate causal insights of how overweight and obesity influence the development
and severity of MIS-C, with the goal of developing strategies for a population that remains at risk for this disease.

Public health relevance
PROJECT NARRATIVE Overweight and obese children are susceptible to a severe inflammatory response (MIS-C) that unpredictably occurs after infection with SARS-CoV-2. Gaps in understanding how and why MIS-C occurs in overweight and obese children hinder risk assessments for MIS-C, thereby amplifying the struggle of communities balancing public health risks against the need for childcare and education. Here, we will determine how pediatric overweight and obesity drive immune cell dysfunction during MIS-C to identify approaches for stratifying a child’s risk to MIS-C.